Leveraging diverse ancestry and environmental variables to understand the evolution and architecture of complex traits

PROJECT SUMMARY
This grant proposes to investigate three critical areas of human genetics: the role of natural selection in
shaping the genetic architecture of complex traits, gene-environment interactions, and demographic history
inference. First, we will model recessive selection on complex traits by leveraging X chromosome data to better
understand the strength of selection across different traits and diseases. Second, we will explore gene-
environment interactions using innovative statistical models, focusing on how genetic risk evolves with age and
environmental exposure. Third, we will develop novel methods based on ancestral recombination graphs to
refine our understanding of human demographic history, including migration patterns and ancient admixture
events. This research will generate new insights into genetic variation, improve the predictive accuracy of
polygenic risk scores, and clarify population histories, with broad applications across diverse genetic datasets.

Public health relevance
PROJECT NARRATIVE Understanding the genetic drivers of complex traits and diseases within and across populations is a fundamental goal in human genetics. Recent large scale biobank projects have collected vast amounts of genomic and phenotypic data, including information about environmental exposures, towards this end, but we currently lack the tools to make full use of these data. This project will develop and apply new statistical tools to understand the evolution of the genetic architecture of complex traits with three major foci: 1) natural selection, 2) gene-environment interactions, 3) demographic history.